Building a Safe, Healthy, and Respectful Workplace for Tradeswomen: A Total Worker Health Approach.

PROJECT SUMMARY
Employees in the skilled trades industries (e.g., construction) are at high risk for injuries and fatalities because
the work is physical and machinery-related hazards are close at hand. Tradeswomen are at even higher risk
for adverse outcomes due to the complex and unique challenges they face, including discrimination and
harassment, poor personal protective equipment fit, and lack of access to safe bathroom facilities. The
objectives of this study fill three major knowledge gaps about women in skilled trade jobs: (1) identify the
unique workplace experiences (both problematic and beneficial) tradeswomen face; (2) quantify the impact
these factors have on tradeswomen; and (3) identify workplace strategies that can improve their safety, health,
and well-being. Our central hypothesis is that multiple factors affect tradeswomen’s Total Worker Health®
(TWH) and can be addressed by strategies based on a systems approach. The long-term goal of this work is
to improve tradeswomen’s safety, health, and well-being by identifying experiences specific to tradeswomen,
and using that knowledge to develop strategies for ensuring a better work life for women workers. Our
approach is based on the Sociotechnical Systems (STS) theoretical framework that will help us to identify key
risk and protective factors typically encountered by tradeswomen by incorporating interactions between people,
the environment, and technology. We will also include factors that influence the overall well-being of
tradeswomen from a TWH perspective. We will identify these key factors and develop organization- and
individual-level strategies for minimizing or promoting them, respectively, in order to support increased safety,
equity, and inclusion in the skilled trades. This project will produce (1) a survey tool that companies can use
to identify key factors that affect tradeswomen’s safety, health, and well-being; (2) a set of strategies, solutions,
and guidelines designed to mitigate key stressors for both tradeswomen (on navigating their unique
environment) and supervisors/organizations (on organizational supports for tradeswomen); and (3) new
materials (e.g., pamphlets, short videos, one-pagers) for research translation and dissemination of this
information/knowledge. We will employ a mixed methods approach by combining qualitative (interviews and
focus groups) and quantitative (survey) data to identify the key factors affecting the safety, health, and well-
being of tradeswomen, and generate strategies for solutions. Project aims are threefold: 1) Identify the
unique safety and health experiences tradeswomen face and quantify the identified factors that influence
tradeswomen’s safety, health, and well-being; 2) Assess the feasibility, benefits, barriers, and facilitators of
various individual- and organization-level strategies that can be applied to improve safety, health, and well-
being for tradeswomen; and 3) Disseminate the knowledge and findings generated in the study (Aims 1 and 2)
to stakeholders and the public.

Public health relevance
PROJECT NARRATIVE Women have been deterred from working in the skilled trades, partially due to the challenging physical, social and organizational work environment, which highlights the need to study this vulnerable, disproportionately at- risk population and better understand the challenges that jeopardize skilled tradeswomen’s safety, health, and well-being. Although fostering equitable gender representation, diversity, fairness, and inclusion is essential for the skilled trades, few studies or publications have addressed the issue or explored strategies for improving working conditions for the purpose of enhancing opportunities for skilled tradeswomen. We will utilize the Sociotechnical Systems and Total Worker Health® approaches to assess the joint impact of factors impeding or enhancing tradeswomen’s safety, health, and well-being, identify needs and improvement strategies, and then disseminate the generated knowledge to key stakeholders and the public in support of a more equitable and diverse workforce in industries that rely on the skilled trades.